Systemic sclerosis (SSc) vasculopathy: Improved clinical monitoring and treatment

? DESCRIPTION (provided by applicant): Systemic sclerosis (SSc; scleroderma) is a multi-organ systemic disease characterized by activation of immune cells, which results in vascular dysfunction (vasculopathy) and subsequent scarring (fibrosis). SSc has a higher than expect prevalence in the US military. Although SSc is heterogeneous in the extent of organ involvement and prognosis, it is accepted that all SSc cases have a progressive and usually devastating course. Since vasculopathy precedes fibrosis in this disease, a focus on understanding its natural history and preventative measures for vascular dysfunction has profound implications. On a national level there are 5,766 SSc patients (ICD-9 710.1) presently cared for in the Veterans Health Administration (VHA). While there is no cure for SSc, studies of therapeutics that can help slow disease progression are valuable to our Veterans. This proposal addresses the solicitation for projects with attention to SSc requested by President Obama after reviewing potential contamination of water at Camp Lejeune. Our proposal is a patient-centered outreach for our Veterans with SSc to inform and prevent catastrophic end- stage vascular abnormalities, including digital ulcers, pulmonary arterial hypertension (PAH) and scleroderma renal crisis in SSc. Additionally, we propose a novel application of a therapeutic for this disease. Our pilot work suggests that measurement of endothelial dysfunction with flow mediated dilatation (FMD) holds promise as novel method to assess disease progression as well as the therapeutic efficacy of the pharmacologic compound tetrahydrobiopterin (BH4) in SSc. We believe that BH4, which targets the endothelium, has great promise to reduce SSc-related tissue hypoxia, end organ damage, and potentially may impact underlying disease progression. The objectives of the proposed studies are to take our pilot work forward. In our first aim, we will adopt an integrative approach and validate a novel, non-invasive technique, FMD to define vasculopathy in SSc. In our second aim, we will examine if BH4 is effective in ameliorating vascular dysfunction in patients with SSc. In our third aim, we will determine the role of oxidative stress in BH4- mediated improvements in vascular function in patients with SSc. Our overarching goal of these aims is to improve vasculopathy detection and management in our Veterans with SSc. A better understanding of the initiating insult and natural progression of SSc vasculopathy is needed in order to develop therapeutics with a goal of curing/treating the underlying disease. This project has the potential to impact not only our Veterans with SSc, but also those with vascular abnormalities including digital ulcers, PAH, and renal crisis. This proposal represents a potential major therapeutic advance for our Veterans with SSc.

Public health relevance
PUBLIC HEALTH RELEVANCE: Systemic sclerosis (SSc) is a devastating illness for our Veterans. In this study, our team of investigators at the Salt Lake City VAMC will perform a patient-centered outreach for our Veterans with SSc to inform and prevent catastrophic end-stage vascular abnormalities, including digital ulcers, pulmonary arterial hypertension (PAH), and scleroderma renal crisis (SRC) in SSc. We propose a novel application of flow mediated dilatation (FMD) and use of a therapeutic (BH4) for this disease. This proposal represents a potential major therapeutic advance for our Veterans with SSc which will impact not only our Veterans with SSc, but also those with vascular abnormalities including digital ulcers, PAH, and SRC.